NRSA Training Core (TL1)

The UC Davis Clinical and Translational Science Center (CTSC) NRSA Training Core (TL1) serves a critical role in preparing predoctoral and postdoctoral trainees during a formative time in their careers. The TL1 is embraced as a critical institutional resource providing structured training pathways that closely align with the needs of individuals and the need to build and grow a translational science workforce. The TL1 program brings significant value to UC Davis and the nation by fostering training and synergies across the institution. The program includes six predoctoral (four graduate students, two medical students) and two postdoctoral fellow (PhD) positions (total of eight). Graduate students and postdoctoral trainees have the opportunity for a two- year training experience and medical students for a one-year training experience. Trainees and mentors across multiple disciplines are selected through a highly competitive application process drawing applicants from the Schools of Medicine, Nursing, and Veterinary Medicine, and the Colleges of Agricultural and Environmental Sciences, Biological Sciences, Engineering, and Letters and Sciences. A new pathway for medical students, the Academic Research Careers for Medical Doctors (ARC-MD) program, is offered to highly qualified applicants and provides continuity of training for a subset of students transitioning from the medical school curriculum to the one year TL1 program. The TL1 provides a creative training and scientific milieu facilitating career development for trainees as independent investigators in academic, government, and industry careers, and members of high-level clinical and translational science teams. The overriding objectives are to facilitate individualized training pathways for a wide-ranging, representative workforce that crosses disciplinary boundaries and to provide a pipeline of trainees to engage in academic, clinical, entrepreneurial, government, or industry-related opportunities. To continue our strong trajectory and build on a successful foundation, the specific goals of the TL1 in the next funding period include: (1) Provide a flexible interdisciplinary curriculum tailored to TL1 trainees that advance translational and clinical research core competencies; and (2) Supplement successful pathways to increase the impact of the translational science research workforce.